Cytokine regulation of recirculating and tissue-resident memory CD8+ T cells in homeostasis and inflammation

Project Summary/Abstract
Memory CD8+ T cells are seeded throughout lymphoid and non-lymphoid tissues in the aftermath of acute
infection. During this process, differentiation occurs into functionally distinct circulating and tissue-resident
subsets which can then persist for years, decades, or even life. However, our understanding of this remarkable
longevity is largely confined to studying circulating populations in homeostasis, neglecting the preponderance of
tissue-resident memory T cells in non-lymphoid tissues and frequent perturbations caused by infection,
inflammation, physiological and metabolic changes, etc. Through the proposed studies, the applicant will begin
to address this knowledge gap by establishing how preexisting bystander memory CD8+ T cell subsets are
maintained during homeostasis and infection via flexible use of cytokines, as addressed with infection models
and cytokine therapy. Despite variable requirements for IL-15 between different memory CD8+ T cell populations,
the applicant recently published that IL-15 sensitivity is a shared feature across memory subsets that operates
within subset- and tissue-specific constraints. Dr. Jarjour proposes that as part of the memory CD8+ T cell
program, memory cells gain the capacity to promiscuously utilize many different cytokines, thereby gaining
resilience to stark alterations in availability during infection and other perturbations. This flexibility appears to
operate within the confines of tissue- and subset-specific regulation, which the applicant will elucidate using his
expertise in studying resident immune cells. Beyond revealing a key mechanism supporting durability of memory
CD8+ T cells, these studies have implications for immunotherapies to expand memory CD8+ T cell populations,
including during vaccination and cancer. The data generated through this proposal will form the basis for an R01
application and will position Dr. Jarjour for an independent career in basic immunology research, with long-term
repercussions for human therapies.

Public health relevance
Projective Narrative Memory CD8+ T cells can be broadly divided into recirculating and tissue-resident populations (or TRM), the latter of which act as first responders against invading pathogens. While substantial study has been devoted to the cytokine requirements of circulating memory CD8+ T cells, much less is known about TRM and how tissue environment affects their self-renewal and maintenance. This proposal will explore cytokine regulation of circulating and tissue-resident memory CD8+ T cell proliferation and maintenance during homeostasis and inflammation to better understand the long-term implications of infection-elicited cytokines and possible therapeutic applications for enhancing CD8+ T cell memory.